Decoding lineage-specific gene regulation across hematopoiesis

PROJECT SUMMARY/ABSTRACT
Sickle cell disease (SCD) and thalassemia are most common genetic disorders worldwide and cause early
mortality and suffering. Reversal of the developmental hemoglobin switch to increase levels of fetal hemoglobin,
encoded by HBG, reduces SCD complications. Previous work over several decades has elucidated several key
transcription factors required to repress HBG expression, but they have proven difficult to target therapeutically
with small molecules. Therefore, a deeper understanding of how cell type and context-specific gene expression
programs are coordinated throughout development is essential to design therapies that reactivate HBG
selectively while sparing other blood cell lineages. While transcription factor recruitment is considered a key
control point for gene specificity, less is known about the selectivity of co-regulatory complexes. This proposal
focuses on one such transcriptional co-activator complex, SAGA, and aims to disentangle its functions
throughout human hematopoiesis. My overarching hypothesis is that despite its ubiquitous expression, SAGA
has gene- and cell type-specific functions across hematopoiesis. Aim 1 elucidates its gene-specific roles using
precision base editing approaches and functional genomics. I will fine-map SAGA subunit functions both
genome-wide and on globin gene regulation during erythroid development and differentiation. Aim 2 investigates
the distinct roles of SAGA amongst human blood cell lineages using both in vitro and in vivo xenograft model
systems. The proposed research builds on my expertise in developmental hematology, genomics, and genome
editing and provides a generalizable framework to dissect the functions of multi-subunit complexes and gene
pathways. Through this detailed molecular mapping of the SAGA complex, I will examine how SAGA impacts
specific loci in primary hematopoietic cells across both lineage and developmental state. While targeting
ubiquitous factors has been viewed as therapeutically undesirable, this proposal revisits this concept by focusing
on SAGA to discover new context-specific functions that could direct future precision therapies for SCD and
other blood disorders.

Public health relevance
PROJECT NARRATIVE I aim to identify novel mechanisms of how SAGA, a widely expressed transcriptional co-regulatory complex, may have gene and lineage specific functions during hematopoiesis. Results from this proposal will provide medically relevant principles of human blood cell formation and identify therapeutic targets for SCD, a painful and life- limiting genetic disorder affecting millions of people globally. I will leverage CRISPR technologies and functional genomics to pinpoint new mechanisms through which to reactivate fetal hemoglobin to treat SCD red blood cells while sparing detrimental effects to other lineages.